Loss of NF1 drives hormone dependent mammary carcinogenesis in a rat model with intact immune system

Loss of NF1 plays a major role as an oncogenic driver in many cancer types and can be found in up to 33% of
all breast cancers (BC). Loss of NF1 is also a prognostic indicator for increased cancer risk at an earlier age,
poorer outcomes, and therapeutic resistance. In addition, certain NF1 genotypes may increase cancer risks,
while others do not. NF1 is largely perceived as a classic Ras-opathy syndrome due to inactivating mutations in
neurofibromin affecting Ras-MAPK signaling. However, recently it has been shown that NF1 binds estrogen
receptor (ER) and acts as a transcriptional corepressor. This helps explain some of these BC findings specifically
in ER+ BC patients. In this model, specific changes to NF1 that abrogate ER signaling lead to Ras driven tumor
resistance to endocrine therapy in up to 20% of ER+ patients as cells are able to grow in low levels of E2 (and
tamoxifen). We have generated novel rat models deficient for Nf1 that have a very robust ER+ BC phenotype,
therefore more closely recapitulating clinical tumors compared to other preclinical models. Our models include a
pathogenic patient missense allele c.3827G>A, p.R1276Q (knockin or KI), associated in humans with spinal NF1
and malignancy, as well as a 14 base pair deletion c.3661_3674del, p.P1220fs*1223 (knockout or KO) model.
Phenotypic differences between our models indicate that the variant matters, and restriction of tumor
development to pregnancy in the KI females indicates hormone induction plays a major role in tumor
development. Rats also develop lung lesions positive for metastatic BC markers. Our overall goal is to
characterize the phenotype of these rat models in terms of histopathology, Ras signaling, hormone signaling,
immune components, and targeted drug response and compare/contrast them with what is known regarding
patients with somatic or germline inactivation of NF1 and breast cancer. Ultimately, this will provide better
prognostic predictions for patients and better therapeutics for treatment. Aim 1 will evaluate tumor onset, growth,
histology, and molecular characterization of Ras and estrogen signaling over time and compare/contrast with
human BC tumor samples. Aim 2 will characterize the Nf1 deficient tumor microenvironment (TME), identify
immuno-targets, and evaluate immuno-targeting with and without Ras-targeting therapeutics. Aim 3 will
evaluate the role of hormones in tumor initiation, maintenance and targeting therapeutics. We will better define
which hormone(s) drive both initiation and maintenance of mammary tumors deficient for Nf1 and utilize this
information to target them both with and without co-targeting Ras to show synergy. As HR+ BC accounts for
~80% of patient cases, and that appropriate mammalian models with intact immune systems are lacking, we
believe that our proposed studies are highly significant and will substantially advance the development of new
therapies to this disease.

Public health relevance
Loss of NF1 plays a major role as an oncogenic driver in many cancer types and can be found in up to 33% of all breast cancers (BC); it is a prognostic indicator for increased cancer risk at an earlier age, poorer outcomes, and therapeutic resistance. We have generated novel rat models deficient for Nf1 including a pathogenic patient missense allele (p.R1276Q knockin or KI) as well as a 14 base pair deletion (p.P1220fs*1223 knockout or KO) allele that have a very robust ER+ BC phenotype with apparent lung metastases. Our overall goal is to characterize the phenotype of these rat models in terms of histopathology, Ras signaling, hormone signaling, immune components, and targeted drug response and compare/contrast them with what is known regarding patients with somatic or germline inactivation of NF1 and breast cancer.